NEUROPHARMACOLOGY OF NEUROENDOCRINE AND NEUROTRANSMITTER REGULATORY MECHANISMS

In the past year, this project has chiefly focused on investigators of the functional status for the serotonin (5-HT) neurotransmitter system in humans using 5-HT-selective agonists (e.g., m-chlorophenylpiperazine (m- CPP), buspirone) and antagonists (e.g., metergoline, trazodone) as pharmacologic probes. Psychophysiologic responses to the 5-HT agonist, m- CPP including blood pressure, neuroendocrine measures, temperature, and subjectively-assessed as well as objectively-rated behavioral changes have been found to be differentially altered in neuropsychiatric patient subgroups. These alterations in responsivity have been found to differ according to dose, time and route of administration of m-CPP. Additional examples of differential responses to other serotonin agonists and antagonists support the concept that humans possess functionally distinct, independently modulated serotonergic subsystems which appear to correspond, at least in part, to the heterogeneous 5-HT binding sites and neuroanatomical subpathways identified in vitro and in vivo in rodents and some other species.